Investigating the role of Microhomology-Mediated End-Joining (MMEJ) in Mitosis and its impact on drug resistance

Project Summary
Deregulation in DNA damage repair pathways can lead to genome instability, loss of genomic
integrity, and ensuing chromosomal abnormalities, all of which are critical events driving the
development of many cancers. A better understanding of DNA damage repair pathways and how
these go awry in malignant transformation could form the basis for more efficacious therapeutic
approaches for various cancers. Mammalian cells have evolved three major pathways to repair
the highly toxic double-strand breaks (DSBs). Homologous Recombination (HR) is the preferred
pathway, which fixes breaks without altering the original sequence. DSBs can also be repaired
by Non-Homologous End-Joining (NHEJ) and Microhomology-Mediated End-Joining (MMEJ).
MMEJ is the most mutagenic mode of DSB repair, mainly because of deletions and insertions
that scar break sites following repair. In 2015, my lab attributed the source of the insertions to the
activity of DNA polymerase theta (Pol coded by POLQ), a low-fidelity enzyme critical for MMEJ
activity.Data from our group and others showed that tumor cells with defective HR highly depend
on MMEJ to repair DSBs. These studies identified Pol as an attractive target for treating BRCA-
mutated tumors with severe defects in HR-mediated repair. Several attempts to target Pol are
underway, and inhibitors are currently in clinical trials as monotherapy and in combination with
PARP inhibitors for treating tumors with BRCA mutations. Based on our previous findings and
preliminary data, I propose in this application a set of experiments to address questions related
to the underlying mechanism of MMEJ at different stages of the cell cycle. In addition, we will
study the function of MMEJ in promoting resistance to targeted therapy, focusing on BRCA
reversion mutations in response to PARP inhibition. Ultimately, uncovering the basis of MMEJ will
provide a better understanding of the source of genomic instability as a function of malignancy
and guide more effective treatment strategies for cancer.

Public health relevance
Project Narrative Microhomology-mediated end-joining (MMEJ) is a poorly understood yet highly mutagenic DNA damage repair pathway essential for the survival of tumors with mutations in the cancer susceptibility genes – BRCA1 and BRCA2. We discovered that polymerase theta (Pol) is a critical MMEJ factor and appears to be a target for cancer therapy. Our goal here is to uncover the mechanistic basis of MMEJ and investigate Pol inhibition in cancer therapy.